Targeting gut-brain axis to eliminate CNS reservoirs

The gut and brain are connected via the gut-brain axis (GBA), wherein the neural and immunological signals are transmitted between the central nervous system (CNS) and the gut. During acute infection, HIV/SIV targets gut CD4+ T cells and macrophages because these sites express high numbers CCR5-expressing activated CD4+ T cells. Targeting of the gut during HIV/SIV infection results in severe depletion of gut CD4+ T cells and ensuing mucosal tissue dysfunction resulting in leaky gut, microbial translocation and chronic immune activation. The integrin α4β7 is found at high levels on the surface of some CD4+ T cells and is involved in gut- cell trafficking. Some strains of HIV/SIV are able to bind to α4β7 on α4β7hi CD4+ T cells making the cells more susceptible to infection. Increased frequency of α4β7hi-expressing CD4+ T cells within the gastrointestinal associated lymphoid tissues (GALT) at the time of infection appears to correlate with increased viral loads and enhanced rate of disease progression. Intravenous (i.v.) administration of anti-α4β7 monoclonal antibody to rhesus macaques protected the GALT from infection when RMs were challenged with either i.v, i.r or IVAG routes. The protection was established by both enhancing the levels of peripheral blood naive, central memory CD4+ T cells. Remarkably, administration of anti-α4β7 mAb to ART-treated SIV-infected RMs resulted in a highly significant, unprecedented suppression of plasma/GALT viral loads even after ART treatment interruption. These studies, taken together, highlight the role of α4β7 in HIV pathogenesis and treatment. Since the gut and brain are connected via the GBA, we hypothesize that controlling viral loads in the GALT will lead to diminished viral reservoirs in gastrointestinal tissues, which indirectly reduces the CNS viral reservoir. To test this hypothesis, groups of macaques will be administrated anti-α4β7 antibody during acute infection along with combination anti-retroviral therapy ART (cART). The viral loads from plasma, CSF and CNS tissue (at necropsy) will be assessed including the measurement of phenotypic characteristics of immune cells and inflammatory markers (Aim 1). Furthermore, sensitive reservoir assays such as viral outgrowth assay (VOA) and highly sensitive Tat/rev Induced Limiting Dilution Assay (TILDA) will be used to measure inducible virus in macrophages/microglia (Aim 2) purified from the brains of the animals in Aim 1, which will identify the establishment of the viral reservoir in the CNS.

Public health relevance
The proposed research in this application is relevant to public health because HIV infection continues to afflict a large number of people worldwide. Even with the development of potent antiretroviral drugs, HIV cannot be eliminated from tissues. Therefore it is important to develop novel therapeutic targets that can be exploited to lead to the ultimate goal of curing HIV infection. This application is aimed at modifying immune cell targeting to reduce the accumulation of infected cells in the both the gut and CNS using monkey as model. In addition, results from this study will determine whether the CNS serves as a viral reservoir during chronic infection and ultimately helps to design strategies to cure HIV.